Flow Cytometry, Microscopy, and Imaging Core

Abstract
The Flow Cytometry, Microscopy, and Imaging (FCMI) Core is a continuation from Phase-1 aimed at providing
a wide range of biotechnology equipment and technical expertise to the COBRE junior faculty pursuing research
on Dietary Supplements and Inflammation. The Core will provide state-of-the-art equipment to the Target and
Pilot Project Faculty and their lab personnel for performing cutting-edge research in an accurate and timely
manner that would lead to successful completion of their proposed projects. One of the focus of this Core is to
provide multi-parameter flow cytometry and sorting services for phenotyping and isolation of specific cell types,
determination of status on cell proliferation, differentiation, apoptosis as well as expression of signaling
molecules and cytokines at the protein level in inflammation and following treatment with botanicals. The Core
will also offer a range of imaging systems for live and fixed cells, tissues and organisms, including labeled and
unlabeled samples. In addition, image visualization, data acquisition, processing and analysis that would meet
the needs of the COBRE investigators are provided. Examination of structural changes that occur in response
to inflammation, and how various dietary supplements induce alterations is critical to the understanding of the
mechanisms of immune dysfunction, and development of therapeutic and preventive strategies. Specifically,
the Core will provide imaging facilities for monitoring these changes at the whole animal to molecular level. This
shared resource will lead to development of biomarkers for early detection and intermediate end points in the
progression of the disease as well as response to therapeutic modalities. Furthermore, the instruments and
expertise will provide specific and sensitive assay systems for determination of various molecular signaling
pathways. At the whole animal level, ultrasound and fluorescence techniques are available to determine how
inflammation and dietary supplements affect the experimental animals. The optical microscopy includes confocal
and multiphoton microscopy for high resolution imaging of tissues to subcellular processes within tissues of
interest. Finally, ultrastructural changes in cells will be imaged by electron microscopy to determine changes at
the sub-micron level of resolution. A full range of image analysis hardware and software is also available to
quantify the structural changes which occur during inflammation in the cells, tissues, and organs and how these
changes are affected by the various dietary supplements. All equipment and technical expertise is available at
USC SOM through outstanding institutional support. The Core faculty and staff will be available for assistance
with experimental design, operation of equipment, and training on imaging instrumentation. In addition to
individual interactions, didactic courses, seminars and workshops are regularly sponsored by the Instrumentation
Resource Facility (IRF) at USC SOM, which will be made available to all members of the Target/Pilot Project
Investigator laboratories.